HERCULES: Exposome Research Center

PROJECT SUMMARY – HERCULES: EXPOSOME RESEARCH CENTER
The Emory Human Exposome Research Center Understanding Lifetime ExposureS (HERCULES)
Environmental Health Core Center has an overarching vision to serve as an intellectual hub in the
advancement and translation of exposome research to improve human health. Our vision is shaped by a
charge to enhance and extend environmental health research, foster innovation and collaboration, engage with
communities and stakeholders, and support research translation to accelerate impact. HERCULES employs
the framework of the exposome, defined as the totality of exposures, biological responses and societal factors
experienced across a lifespan, which impact the environment experienced by an individual. HERCULES
Members comprise 71 researchers from 24 departments at Emory University and the Georgia Institute of
Technology, connected by a shared mission of learning how the exposome affects health and community well-
being and using that knowledge to improve human health. The overarching goals of the Center are to a)
innovate in the tools, application, and data science of exposome research, b) promote and grow translational
environmental health research at Emory and Georgia Tech, and c) strengthen and expand partnerships with
metro Atlanta area communities to enhance their ability to assess their exposome and respond to their
environmental health priorities. To achieve these goals, HERCULES supports an Integrated Health Sciences
Facilities Core, which operationalizes the exposome concept within a targeted analysis facility, an untargeted
high resolution metabolomics facility, and translational research unit, as well as an Environmental Health
Data Sciences Core to enable and interpret multidimensional exposomic output, providing an ecosystem of
data sciences services. The Community Engagement Core serves to define and apply exposomics through
bi-directional interactions with community groups and stakeholders and leads a program of community
engagement and support. Our highly successful Pilot Project Program innovates exposome research, with
priorities on early career investigators, translational, and community-engaged research through both larger
traditional pilots and smaller, time-sensitive awards. The Center’s Administrative Core coordinates activities
and communication and uses evaluation to ensure that the Center’s goals are achieved. A career development
program also will support targeted early career investigators recruited to Emory and the Center and will provide
support for both early career and established investigators to develop new skills or research directions. In its
vision, aims, and diverse community of members and stakeholders, HERCULES serves as the home to
environmental health research at Emory University, Georgia Tech, and the metro Atlanta area, providing
infrastructure, scientific leadership, and collaborative resources for our members to develop and implement
innovative exposome research and improve human health.

Public health relevance
PROJECT NARRATIVE – HERCULES: EXPOSOME RESEARCH CENTER Using the framework of the exposome, which encompasses the totality of exposures, biological responses and societal factors experienced across a lifespan, the HERCULES: Exposome Research Center at Emory and Georgia Tech work to enhance and extend environmental health research, foster innovation and collaboration, engage with communities and stakeholders, and support research translation to accelerate impact.